Antibody Biomarkers of Cryptococcosis in Immunosuppressed Solid Organ Transplant Recipients

Project Abstract
Dr. Hyun Ah Yoon proposes a mentored clinical and translational research project and career development plan
to identify antibody (Ab) biomarkers of risk for cryptococcosis in organ transplant recipients being started on
immunosuppression. Her study will test the hypothesis that immunosuppression induces changes in plasma
immunoglobulin (Ig) levels and cryptococcal capsular polysaccharide glucuronoxylomannan (GXM)-binding,
and/or naturally occurring laminarin-binding Ab levels, and that these changes correlate with the risk of
cryptococcal disease in relation to the presence of absence of Ab functionality. Her published data support the
hypothesis and aims demonstrating that compared to controls, relative differences in plasma Igs, GXM- and
naturally occurring laminarin-binding Ab levels were associated with cryptococcosis. To test her hypothesis, In
Aim 1, Dr. Yoon will retrospectively identify kidney transplant candidates from an ongoing longitudinal
prospective study at Montefiore Medical Center (MMC) who are about to start immunosuppression and do not
have cryptococcosis. She will then determine Ab levels over 3 years as a function of immunosuppressive drug
type, dosage, blood level and duration. In Aim 2, she will analyze the plasma Ab function of organ transplant
recipients diagnosed with cryptococcosis at MMC and University of Alabama at Birmingham to identify Ab
correlates of protection against disease or progression over a year. Her study will generate new knowledge on
the effect of immunosuppression on Ab markers and how Ab functional attributes correlate with cryptococcosis
risk and/or disease outcome in high-risk organ transplant recipients. The long-term goal is to identify HIV-
negative patients at risk for cryptococcosis or poor clinical outcome earlier, intervene, and reduce morbidity and
mortality by testing the proposed Ab biomarkers in a multi-center prospective clinical trial. The proposed training
plan includes a combination of didactic training and mentored clinical and translational investigation that will
allow Dr. Yoon to build on the preliminary data and essential laboratory and analytic skills she started to develop
during her master’s degree in clinical research methods at Einstein, which she completed with distinction in May
2022. Her career development plan proposes mentored training in 1) laboratory techniques in Ab immunology,
2) longitudinal study design and analysis of comprehensive clinical and translational data, 3) leveraging her data
to develop an independent grant proposal to conduct a clinical trial applying the biomarkers. Additional training
will be accomplished by enrolling in advanced didactic courses and presenting at national and international
conferences. Dr. Yoon will be mentored and guided by renowned mentors and collaborators with extensive
experience in cryptococcal pathogenesis, Ab research, fungal immunology, clinical and translational research,
and epidemiology/biostatistics, which will allow her to develop her own distinct research trajectory. Upon
completing this project, Dr. Yoon will have acquired substantial breadth and depth of clinical and translational
research training and be well-positioned to begin an independent research career and pursue extramural funding.

Public health relevance
Project Narrative Fungal diseases are on the rise, and one of them, cryptococcosis, causes devastating meningoencephalitis in immunosuppressed individuals, including organ transplant recipients. There are no biomarkers to detect risk or early stages of disease in individuals on immunosuppressive drugs. This project is designed to discover antibody biomarkers to identify those at risk for disease.